The role of MER/PROS1 in promoting stromal induced emergence from metastatic melanoma dormancy

Project Summary
The goals of this Pathway to Independence Career Development proposal are to request support for Dr. Fane
to develop training in tumor dormancy and underlying cancer immunology and bioinformatics techniques to
investigate how dormant melanoma cells located within metastatic tissues can regulate stromal cells to facilitate
metastatic outgrowth and resistance to therapy. The training plan outlined in this proposal will take advantage of
the extensive resources and career development programs available at Johns Hopkins. Dr. Fane has assembled
a team of leaders in the field of melanoma, dormancy, immunology, and bioinformatics who will guide his training.
Metastasis is the largest cause of melanoma deaths, with treatments failing to provide a durable response. While
a subset of patients show-remarkable responses initially to therapy, most of them will have tumor cells lying
dormant in distal organs that persist during therapy but are clinically undetectable. Eventually, these cells will
‘reactivate’ from dormancy to form metastatic colonies, now resistant to therapy. There are few labs that focus
on melanoma dormancy and as such, there are no current treatments or diagnostic tools to identify and target
dormant cells. The proposed studies are based on Dr. Fanes novel findings that upregulation of the tyrosine
kinase receptor MER promotes cancer growth, which allows ‘reactivation’ of dormant melanoma cells within the
lung. It isn’t known how ‘reactivated’ cells overcome targeting by the immune system, growth restrictive cues
from lung fibroblasts, or how they become resistant to therapy. Dr. Fanes preliminary data first shows that
MERhigh melanoma cells regulate lung fibroblasts to alter secretion of the extracellular matrix, changing it from
being dormancy promoting to allowing melanoma outgrowth. Dr Fane has also shown that following ‘reactivation’
of melanoma within the lung, there is an increase in Myeloid Derived Suppressor Cells (MDSCs) and T-regulatory
(Tregs) cells which inhibit the immune system from targeting cancer cells for destruction and are often a common
feature in patients resistant to immunotherapy. Finally, Dr. Fane has shown that ‘reactivated’ melanoma cells
secrete high levels of the soluble protein PROS1, which is known to be involved in regulating the activity of
MDSCs, Tregs, and lung fibroblasts within other disease states, but has not been investigated in metastatic
dormancy. Dr. Fane will explore the following scientific aims: 1) Determine whether MER induced secretion of
PROS1 regulates lung fibroblast to promote outgrowth and therapy resistance and 2) Investigate the mechanism
by which MER induced secretion of PROS1 by melanoma cells in the lung regulates immune cells and response
to -PD1. The completion of the scientific aims in this proposal will develop Dr. Fanes scientific and professional
skills that are required to be an independent investigator into the field of dormancy and importantly, will provide
novel insight into how cancer cells overcome targeted and immunotherapies in dormant, metastatic disease.

Public health relevance
Project Narrative The major source of melanoma deaths is metastatic disease, largely due to the fact that while tumor removal and therapies look promising for patients in the beginning, a large subset of patients will have tumor cells that have left the primary tumor site and are in a state of ‘dormancy’ in other organs, which remain resistant to these therapies and are unable to be detected by clinicians. We have uncovered a receptor called the MER tyrosine kinase receptor that when expressed in dormant melanoma cells, results in their ‘reactivation’ and drives aggressive tumor growth in the lung. We propose to study how these ‘reactivated’ melanoma cells secrete soluble proteins into the lung to stop our immune system and other healthy cells such as fibroblasts from targeting melanoma cells for destruction, and how this process can also lead to resistance against targeted and immunotherapies, with the hope of finding pathways that can be targeted clinically for translational therapies against dormant and reactivated metastatic melanoma.